Improving cryopreservation outcomes of small biological samples through ultra-fast convective cooling and warming

Project Summary/Abstract
Cryopreservation of oocytes, embryos and other small biological samples plays a key role in medicine, in
biomedical research, and in assisted reproduction of humans, domestic animals, biomedical research animals,
and endangered species. Hundreds of thousands of genetically distinct strains of species including pigs, fruit
flies, and zebrafish are maintained for biomedical research purposes. Many species/strains are maintained as
live stocks or are propagated by cloning because reliable and cost-effective oocyte/embryo cryopreservation
technology is not available. Such technology would provide benefits including simplification of protocols,
protection against genetic drift from generation to generation, preservation of culled stocks, and protection
against disasters. Current cryopreservation approaches involve soaking samples in cryoprotectant solutions,
cooling by hand plunging in liquid nitrogen, and warming by hand plunging in a warm solution. Poor post-thaw
survival and development outcomes are primarily associated with ice formation, although osmotic shock during
soaks, cryoprotectant toxicity, sample microfracturing, and phase transitions and chemical changes in lipids can
contribute. Some improvement in cryopreservation outcomes has been achieved using alternative warming
methods based on, e.g., electromagnetic energy absorption by injected nanoparticles.
This project aims to develop and validate cryopreservation technology that automates soaking, cooling, and
warming; that optimizes conventional convective heat transfer to increase cooling rates in liquid nitrogen and
warming rates in aqueous solutions by factors of 102 over current practice; that can eliminate ice formation and
associated damage and allow cryoprotectant concentrations to be reduced; that reduces cooling and warming
times toward ~1 millisecond, allowing other damage mechanisms to be outrun; and that improves reproducibility
of key steps, facilitating optimization of other factors important to successful outcomes. This work is informed by
studies of ice formation in aqueous solutions during fast cooling and warming; by MiTeGen’s expertise and
technology base in ultra-fast cooling using liquid nitrogen; by expertise in diagnostics including time-resolved x-
ray diffraction and high speed optical imaging that can detect and quantify ice formed in oocytes/embryos during
cooling and warming; and by extensive preliminary studies on bovine oocytes and embryos demonstrating the
feasibility of fully ice-free cryopreservation and how ultra-fast cooling improves developmental outcomes.
Technology to be developed includes a flexible robot-based workstation with stations for soaking, liquid
removal, ultra-fast cooling, and ultra-fast warming; and ultra-low thermal mass sample supports that maximize
convective cooling and warming rates while retaining samples through all steps. This technology will be
validated, first, through measurements of cooling/warming rates and ice formation in aqueous cryoprotectant
solutions and, second, through studies of ice formation in and post-thaw survival, development, and
transcriptomes of bovine and porcine embryos.

Public health relevance
Project narrative Cryopreservation of oocytes, sperm, and embryos can play a key role in propagation of animals used in biomedical research and in preserving the genetics of the thousands to hundreds of thousands of strains of each species that have been developed. Advances in understanding ice formation during both cooling and warming and its developmental consequences combined with new technology for automated ultra-rapid convective cryocooling and ultra-rapid convective warming promise to increase cryopreservation success rates, expand the range of species and strains that can be successfully cryopreserved, and facilitate their biobanking. These advances may also impact human assisted reproduction, preservation of endangered species, and biobanking of other small biological samples.